A System for the Large‐scale Production of Membrane Proteins

Membrane proteins play a fundamental and critical role in cellular processes. Their direct link to
human disease as well as their key role in signal transduction, has made many membrane proteins the
foremost targets for chemotherapeutic intervention with more than 50% of all drugs designed to modulate the
activity of this class of proteins. Despite this central role in human health, the biochemical, functional and
structural properties of membrane proteins remain poorly understood. This is partially due to the inherent
challenges of isolating membrane proteins in sufficient quantities and levels of purity needed for biochemical
characterization. The traditional approach of using heterologous protein expression systems to synthesize
recombinant membrane proteins has been marginally successful. No one system has emerged as universally
applicable and the process of producing recombinant membrane proteins remains one of trial and error. To
address this bottleneck in the study of membrane proteins and in the development of new treatment options,
we have proposed the use of the thylakoid membrane system of the unicellular green algae Chlamydomonas as
a more suitable platform for the production of recombinant membrane proteins. The proposed research aims
to demonstrate the feasibility of using such a system by building a set of specialized vectors that direct the
expression of membrane proteins to the thylakoid membrane and to test the utility of the system using two
medically relevant membrane proteins.

Public health relevance
As membrane proteins have a critical role in cellular function, they play a central role in human health. A more thorough understanding of their biochemical, functional and structural properties would have direct implications to the understanding of the molecular basis of disease as well as toward the development of new chemotherapeutic treatments. Thus, an effective system for reliably producing and isolating membrane proteins in a highly pure and functional state would directly impact human healthcare.